Understanding the interaction between sleep and SHANK3/B-catenin signaling in Autism

PROJECT SUMMARY
Sleep problems occur at a higher rate in Autism Spectrum Disorder (ASD) than in typical
development. Problems falling asleep predict severity of ASD core symptoms and associated
problem behaviors, and lead to chronic sleep deprivation (SD). Understanding the effects of sleep
deprivation is important because it adversely affects cognition, attention and emotional regulation.
Nonetheless, little is known about the mechanisms responsible for abnormal sleep or the
consequences of chronic sleep loss in ASD. Identifying these mechanisms may lead to new
interventions that will improve quality of life of patients and their families. The study of genetic
syndromes with high rate of ASD diagnosis has provided important clues into mechanisms. One such
syndrome is Phelan McDermid Syndrome (PMS), characterized by deletions in the SHANK3 gene.
Mutations in SHANK3 are also often found in patients with idiopathic ASD. We previously showed
that the ASD sleep phenotype is recapitulated in mice with a C-terminal deletion in Shank3
(Shank3∆C), which struggle to fall asleep despite being sleepy (i.e. after SD). We also showed that SD
induces greater number of differences in gene expression in Shank3∆C animals than WT. Therefore,
we hypothesize that Shank3∆C animals display an abnormal transcriptional response to SD. The
objective of this proposal is to identify the mechanisms that underlie the abnormal response
to SD in ASD, using Shank3 mutant mice as a model. Our preliminary studies show that SD
increases the nuclear localization of full-length SHANK3a, an isoform that is absent in Shank3∆C
animals and thought to be primarily synaptic. SHANK3 binds b-catenin. Translocation of β-catenin
into the nucleus regulates transcription through chromatin remodeling and is key to many
developmental processes. Our preliminary studies show that SD produces changes in chromatin
topology in glutamatergic neurons, and that some of these changes do not take place in Shank3∆C
animals. Therefore, our central hypothesis is that SD changes chromatin topology and gene
expression by increasing nuclear SHANK3a and b-catenin and that the absence of SHANK3a in
Shank3∆C interferes with this process. To test our hypothesis, in Aim 1, we will first determine the
effects of SD in SHANK3a/b-catenin synaptic-nuclear signaling. Then, in Aim 2, we will determine the
effect of SD in SHANK3-dependent chromatin topology and transcription at single-nuclear resolution.
We will examine two brain regions important to ASD and impacted by sleep loss: pre-frontal cortex
and hippocampus. We will subsequently test candidates prioritized through omic studies for their
ability to influence sleep. Completion of these aims will allow us to determine how sleep interacts with
SHANK3 and β-catenin to regulate chromatin and gene expression.

Public health relevance
PROJECT NARRATIVE Problems falling and staying asleep are extremely prevalent in individuals with Autism Spectrum Disorder (ASD); but the relationship between how sleep and sleep loss affect the brain and how it may be different in ASD are poorly understood. This project is relevant to public health because we will investigate the relationship between sleep deprivation and ASD in a human-relevant model to better understand mechanisms and pave the way to targeted therapies and interventions.